Validation of next-generation TMS system optimizing for widely scalable, personalized treatment of depression

SUMMARY
Depression affects approximately 280 million people worldwide. Despite widespread access to antidepressant
medications and psychotherapy, the prevalence of depression and, in turn, suicidality is increasing. In 2008,
the US Food and Drug Administration (FDA) approved transcranial magnetic stimulation (TMS), an effective
non-pharmaceutical treatment that alleviates depression, even in cases otherwise deemed treatment-resistant.
More recently, the FDA approved Stanford Neuromodulation Therapy (SNT), an advanced TMS protocol that
fine-tunes the stimulation target using functional magnetic resonance imaging (fMRI). This protocol boosts
TMS efficacy (~80% symptom remission) and speed (5 treatment days). However, SNT-type therapy requires
large, expensive, difficult-to-operate equipment and highly specialized personnel, which severely limits its
scalability, accessibility, and overall capability to yield meaningful reductions in the nationwide prevalence of
depression and suicidality.
Ampa Health has an overarching goal to democratize access to state-of-the-art depression treatment by
developing a next-generation TMS system that eliminates the need for large equipment and highly skilled
technicians, thereby making treatment dramatically less expensive and more scalable. The technology we are
developing will make it possible for patients to receive highly effective SNT-type therapy in almost any setting.
Our NextGenTM TMS system comprises three key innovations: (1) Precision TMS targeting based on
neurocardiac response signals to replace fMRI-derived targeting; (2) neuronavigation using a camera + scalp
cap system instead of cumbersome, hard-to-master, fMRI-based frameless stereotaxy; and (3) optimizing the
stimulation pulse waveform to minimize power requirements, in turn minimizing the size and weight of the
overall TMS device. Having demonstrated proof-of-concept across all three system elements in Phase
1-equivalent work, we propose Phase 2 work to optimize and validate the NextGen TMS system for
commercialization. Specifically, we will: Validate our neurocardiac response markers against gold-standard
fMRI target localization (Aim 1); validate the precision of our FoveaTM Coil + navigation cap system for coil
placement against gold-standard frameless stereotaxy (Aim 2); and identify the optimal pulse width for
maximum power efficiency (Aim 3). As evidence of the therapeutic potential for TMS to alleviate severe,
treatment-resistant depression continues to accumulate, the clinical necessity of these advancements is
difficult to overstate. Our portable, cost-efficient, easy-to-operate system promises to maximize access to
highly effective depression treatment, including the potential for at-home TMS in the future.

Public health relevance
PROJECT NARRATIVE Severe depression and suicidality affects approximately 280 million people worldwide despite widespread access to antidepressant medications and psychotherapy. Transcranial magnetic stimulation (TMS) has recently emerged as a non-pharmaceutical treatment that can achieve remission of otherwise treatment-resistant depression, however, effective TMS therapy relies on specialized functional MRI (fMRI), and other large, expensive, and difficult-to-operate equipment, which severely limits access and scalability. Towards a solution that has the potential to meaningfully reduce the disease burden of severe depression, we are developing a novel TMS delivery system that eliminates the need for fMRI data, simplifies neuronavigation and precision targeting, and dramatically reduces the size and weight of the device overall.